Administrative Core

Administrative Core
ABSTRACT
The Administrative Core supports the translational research objectives of the SPORE by providing: 1) centralized
administrative support of the daily activities of the SPORE Program, (2) coordination for all educational and
scientific activities of the SPORE, including three research projects, three cores, a Developmental Research
Program (DRP), and a Career Enhancement Program (CEP), and (4) scientific programmatic oversight of
projects and cores in collaboration with internal and external advisory boards. This work will be performed under
the direction of the Principal Investigator, Samuel Singer, MD. The Administrative Core will also include a team
of experienced personnel trained in financial management, operations, grants administration, medical editing,
and data management. Administrative Core members will work as a team to ensure the effective financial and
administrative management of the SPORE. The Administrative Core is responsible for the following: submission
of reports and non-competing renewal applications to the NIH, facilitating communication among SPORE
investigators, organization of conferences and seminars, management of the clinical soft tissue sarcoma
database and biospecimen bank, and coordination of meetings and other communication to ensure consistent
scientific review of ongoing SPORE research. The Core will also be responsible for annual solicitation of new
applications for the DRP and CEP, fostering communication with other SPOREs pursuing related research and
the wider scientific community, and sharing genomic and other molecular data and linked clinical annotation in
a manner that assures patient privacy and compliance with all federal and state regulations. The centralized
services of the Administrative Core will ensure the effective financial and administrative management of the
SPORE.